Diet, Gut Microbiota, and Heart Failure

PROJECT SUMMARY Heart failure (HF) is a growing, morbid, and costly public health problem. Consequently, there is increasing realization for the importance of early detection and prevention. Preliminary data suggests a meta-organismal pathway involving formation of trimethylamine N-oxide (TMAO) is a direct contributor to heart failure susceptibility and adverse prognosis. The novel pathway involves a complex interplay between chronic dietary exposure of specific dietary nutrients, gut microbe metabolism of these nutrients using specific microbial enzymes, and then host hepatic metabolism of the microbial waste product, ultimately producing a biologically active compound, TMAO. Preliminary studies show TMAO adversely influences myocardial function and promotes both myocardial fibrosis and heart failure phenotype. We propose to examine the role of specific chronic dietary exposures alternative to sodium in risk for adverse cardiac remodeling and heart failure, and to understand their potential mechanistic underpinnings. We will examine the role of gut microbes in heart failure susceptibility, and specific microbial enzyme systems in this process. Finally, we will explore the potential efficacy of therapeutic dietary approaches targeting this pathway for the prevention and treatment of heart failure. Successful completion of the proposed studies should provide both important mechanistic insights into a new pathway that contributes to heart failure development and progression, as well as develop novel diagnostic tests and therapeutic approaches for the treatment of heart failure.

Public health relevance
PROJECT NARRATIVE (DESCRIPTION) Our overall goal is to test the hypothesis that gut microbes, via metabolism of specific dietary nutrients, participate in the development of heart failure. The proposed studies may further identify individuals at greater risk for development of ventricular dysfunction, cardiac remodeling and heart failure. They focused on the elucidation of the contribution of gut microbes to heart failure development, mechanisms involved, and identification of therapeutic strategies to modulate gut microbiota linked to heart failure development and progression.